A Feasibility Study to Test the REST Tracker System for Use in Maternal Care to Improve Outcomes by Early Detection of Obstructive Sleep Apnea

Abstract
Obstructive sleep apnea (OSA) during pregnancy is associated with increased risk of developing gestational
diabetes, hypertension, preeclampsia, and eclampsia, contributing to maternal and neonatal morbidity and
mortality. Furthermore, OSA increases risk of chronic cardiovascular disease, well beyond pregnancy, raising
the stakes for detection and management during pregnancy. Research studies suggest that the prevalence of
OSA increases during pregnancy, as the maternal body mass index (BMI) rises. Continuous evaluation is
necessary as the risk of developing OSA increases throughout the course of the pregnancy however this is not
currently a standard practice in prenatal care. Serial screenings for OSA with polysomnograms or home sleep
apnea tests are impractical and financially prohibitive. Thus, the need arises for improved tools that provides
simple and accurate detection of OSA during pregnancy to prevent potential consequences. Sleep specialists
have not provided a specific approach to assist obstetricians addressing OSA concern, leaving a gap in our
maternal health management. Our proposal seeks to address this gap.
REST Technologies has been involved with providing services to support clinical sleep medicine for the past
twenty years. Now, using remote patient monitoring, state-of-the-art signal processing, and data reduction
techniques REST Technologies REST Tracker system can improve maternal health. Additionally, beyond the
detection of OSA during pregnancy, OSA treatment management itself can be optimized using this same
monitoring approach. The progressive physiologic changes in pregnancy make it an ideal population for the
REST Tracker system development, as the approach is generalizable to other at-risk populations. This grant
focuses on demonstrating feasibility to perform Remote Patient Monitoring to track pregnant patients throughout
their pregnancy is a fashion that is simple for the patient yet yielding critical data that relates to sleep and sleep
physiology. The team assembled for this project have vast clinical experience and plan to bring innovative
approaches to the practice of sleep medicine beyond maternal monitoring to enhance Telemedicine clinical
pathways.

Public health relevance
Project Narrative Rest Technologies, INC seeks to develop The REST Tracker System leveraging an FDA-approved wearable ring to improve outcomes in maternal care by early detection of Obstructive Sleep Apnea.